Use of the Baboon Model of Pertussis to Evaluate Strategies for Next Generation Pertussis Vaccines

This IAA will support work to advance our scientific understanding of host responses to pertussis infection and vaccination and will guide the development of improved pertussis vaccines.